Role of cholinergic neuroimmune signaling pathway disruption in the pathogenesis of Hirschsprung-associated enterocolitis

PROJECT SUMMARY
Hirschsprung disease (HSCR) is a congenital disorder of gastrointestinal tract characterized by
the absence of enteric nervous system (ENS) along variable lengths of distal intestine. Children
with HSCR are at risk for a devastating bowel inflammatory disorder, called Hirschsprung-
associated enterocolitis (HAEC), that represents the leading cause of long-term morbidity and
mortality and is associated with significant healthcare costs. Gaps in therapy are due to our
incomplete understanding of the molecular and cellular causes of this condition. While lack of the
ENS and immune dysregulation have been implicated in the pathophysiology of the HAEC, little
is known about the role of neuroimmune interactions, which are so important in multiple functional
gastrointestinal diseases. Our broad objective is to characterize the neuroimmune mechanisms
underlying HAEC and to leverage this knowledge to test cell-based strategies to restore immune
homeostasis and improve epithelial barrier function and the gut immunity. Based on our
preliminary data, we hypothesize that disruption of normal ENS-innate lymphoid cell (ILC)-tuft cell
(TC) interactions leads to the development and progression of intestinal inflammation. By utilizing
murine model of HSCR, cell and organoid co-culture technologies, optogenetics, and cell
transplantation techniques, we propose to test our hypothesis that loss of ENS in the aganglionic
bowel of HSCR leads to disfunction of ILC-TC circuit that is associated with alterations of epithelial
architecture and immune cell infiltration and disrupted intestinal innate immunity. We will also test
our hypothesis that enteric neuronal cell therapy and optogenetic approach can restore immune
homeostasis in vivo. The proposed studies will enhance our understanding of the role of the ENS
in the immune dysregulation and marked declines in ILC and TC populations observed in the
HAEC, and the results will allow us to identify novel potential therapies that target the primary
cause of HAEC pathophysiology.

Public health relevance
PROJECT NARRATIVE Hirschsprung-associated enterocolitis, which is a dangerous bowel inflammatory condition frequently suffers children with Hirschsprung disease, a developmental disorder of the enteric nervous system. The goal of this project is to characterize the neuroimmune pathways that underlie Hirschsprung-associated enterocolitis in mouse, focusing primarily on the relationship between enteric nervous system and immune homeostasis in the intestinal wall. We will also leverage cell-based therapy and optogenetics as a mechanism of restoring neuroimmune homeostasis and improving intestinal epithelial barrier and gut immune function.